Commercialization of a phylogenetic cell separation method for downstream purification of nucleic acids

Abstract
The success of all microbiome-based studies is highly dependent on effective sample purification of the
target organisms of interest. Characterizing individual organismal components of these metagenomic samples
relies heavily upon the ability to separate the individual phylogenetic components, such as removing human
cells from the microbiological fraction while preventing sample loss or degradation. This Phase II STTR project
aims to continue the development of and commercialize a patent pending simple and inexpensive purification
approach aimed at effectively separating and preserving host and microbial DNA from a metagenomic sample.
This method will ensure all organismal DNA is preserved (i.e., not “sacrificed” or lost) during initial separation
steps, unlike protocols employed by existing DNA purification kit manufacturers. Outcomes result in higher
quality DNA sequence data (i.e., higher sequencing coverage and higher sensitivity), thus providing robust
information content, leading to higher confidence in organismal characterization.
Syracuse Biolabs, Inc. (SBL), has teamed with scientists in the Forensic and National Security
Sciences Institute (FNSSI) at Syracuse University to further improve and commercialize this novel DNA
purification approach. The Phase I project clearly demonstrated the superiority of the Syracuse Method to
currently available kits from Qiagen and Zymo Research. This Phase II project has five aims directed toward
continued development of the method into a commercial product for fieldable cell/DNA purification modules of
metagenomic samples. Our metagenomic DNA purification kit is also applicable to fields outside of the human
microbiome research market, including forensic identification and geolocation of biological samples relevant to
criminal and intelligence related activities, DNA based ecological research, plant and microbial based
geosourcing, and defense/homeland security efforts (requiring DNA purification from environmental samples).

Public health relevance
Narrative This Phase II project will further develop and validate a novel, cost-effective approach to separate and preserve metagenomic cells/DNA for downstream qPCR or next-generation DNA sequencing analysis. If successful, this technology with be developed into salable cell/DNA separation and purification kits targeting metagenomic DNA analysis applications in healthcare, microbial research, and forensics.